Administrative Core

ABSTRACT – ADMINISTRATIVE CORE
The Florida-California Cancer Research, Education & Engagement (CaRE2) Health Equity is a partnership
among the University of Florida (UF), Florida A&M University (FAMU) and University of Southern California
(USC) to eliminate cancer health disparities in Florida, California and nationally. Building on the strong foundation
and Center accomplishments that met or exceeded the benchmarks set for the first 5-year funding cycle, we
propose another 5 years of support for our cutting edge work. The Administrative Core of the CaRE2 Center will
serve as the hub of the CaRE2 Center’s activities, including the management, coordination, supervision and
promotion of the Center’s activities. The administrative leadership will be primarily responsible for the Center’s
strategic planning, including: defining and upholding its mission and objectives, conducting environmental
scanning for strategy development, directing and managing strategy implementation, and ensuring adjustments
are made for continuous quality improvement (CQI) based on program evaluation. The established benchmarks
for the success of the Administrative Core are: (1) Integrated research efforts focused on cancer disparities
research by a minimum of 12 UF-FAMU-USC collaborative teams. Three research projects are submitted as
part of this application and we anticipate making three additional awards between Years 2 and 4 and six
projects supported with a Developmental Research Program and leverage funds (with additional extramural
projects anticipated); (2) Integrated research education efforts focused on increasing the pool of
underrepresented minorities focused on cancer research; (3) Integrated community outreach efforts focused
on engaging minority populations to collaborate on cancer research that reflects mutual interests; (4)
Successful dissemination efforts that address cancer disparities in sub-populations of Black/African American
and Hispanic/Latinx individuals via the Center’s websites, publications, webinars, conference presentations,
community outreach events, and educational activities; and (5) Submission of NIH K-series, T-series, and
R-series grants led or co-led by a FAMU investigator and led by early stage investigators.